Skills to Enhance Positivity in Suicidal Adolescents

DESCRIPTION (provided by applicant): The prevalence of suicidal behaviors in adolescents remains unacceptably high. Reviews of published randomized controlled trials (RCTs) for adolescent suicidality conclude that treatments to date have been minimally efficacious. The preponderance of interventions focus on crisis intervention, underlying psychiatric disorders, regulating negative affect and reducing cognitive distortions. However, our pilot work and other recent data suggest the importance of considering how low positive affectivity contributes to suicide risk independent of other risk factors and may be another mechanism that leads to suicidal behaviors. Our model is based on Fredrickson's empirically-supported Broaden and Build model which asserts that the function of positive affect (PA) includes helping individuals thrive by improving social supports, problem-solving, and personal resilience. Each of these areas is instrumental in decreasing suicidal behavior. We propose that PA increases survival directly by decreasing suicidal ideation and indirectly by increasing social support and problem-solving. In this R34 treatment development grant we seek to develop a novel, individual skills-based, PA intervention, delivered adjunctively to treatment as usual (TAU), targeting the highest risk adolescents - those hospitalized due to suicide risk. We focus on three strategies that have been demonstrated to increase sustainable (vs. transient) PA in community and depressed adults: meditation, gratitude, and savoring. There are several ways to practice each strategy; we take into account patient preferences in a personalized approach in which patients select the practice(s) that fits best with their needs and circumstances. We propose using multiple means of intervention delivery that includes a new technology medium of their choosing, to reinforce in-vivo practice. Our intervention, Skills To Enhance Positivity Program (STEPP) includes two phases: a) in-person phase consisting of 3 individual in-person sessions and 1 joint parent session during the inpatient hospital stay to teach PA skills and develop a personalized intervention; b) remote delivery phase which consists of weekly telephone booster calls and daily text or email messages over 4 weeks post-discharge. The phone calls will be used to review or adjust personalized intervention components and reinforce use of skills. The text/email messages will include self-scripted reminders to practice skills and links to online resources. Text vs. email delivery will be based on accessibility and preference. STEPP will be tested in an open trial with 20 participants, and after further revision, in a pilot RCT, compared to TAU in a sample of 50 adolescents. The primary goal of this intervention is for patients to increase positive affect by incorporating skills and practices into their normal home-based routines, which we believe will lead to increases in problem-solving and social support and decreases in suicidal ideation. Our proposal meets NIMH Strategic Objective #3. This is a novel intervention for a high-risk acute population via a different mechanism (i.e. PA), and conceptually distinct from other empirically examined theoretical approaches.

Public health relevance
PUBLIC HEALTH RELEVANCE: The prevalence of suicidal behaviors in adolescents remains unacceptably high and is a significant public health concern. We propose a new treatment approach in which skills to increase positive emotions are taught to the most vulnerable at-risk adolescents, those admitted to an inpatient psychiatric unit due to suicide risk. We believe that teaching skills to increase positive emotions will lead to better problem-solving, increased social support, and other benefits which will serve as protective factors and decrease suicide risk. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS Suicide is the third leading cause of death in the 15-24 age group and accounts for more deaths than all natural causes combined. Since 1980, the rate of suicide deaths among adolescents has increased by 11%. Although recent years have seen significant advances in our knowledge of efficacious treatments for many psychiatric disorders, the suicide rates in this country have not decreased substantially. Reviews of published randomized controlled trials for adolescent suicidality conclude that treatments to date have been minimally efficacious. The preponderance of interventions focus on crisis intervention, underlying psychiatric disorders, regulating negative affect and reducing cognitive distortions. However, our pilot work and other recent data suggest the importance of a transdiagnostic approach, and of considering how low positive affectivity contributes to suicide risk independent of other risk factors (including high negative affectivity), and may be another mechanism that leads to suicidal behaviors. A focus on both positive and negative affect is important because emerging research indicate that opposite emotion valences are not on the same continuum (e.g. they have different neural substrates). Our model is based on Fredrickson's empirically-supported Broaden and Build model which asserts that the function of positive affect includes helping individuals thrive by increasing social supports, improving problem-solving, and increasing personal resilience. Each of these areas is instrumental in decreasing suicidal behavior. Our application of the Broaden and Build model to suicidal behaviors asserts that positive affect increases survival directly by decreasing suicidal ideation and indirectly by increasing social support and problem-solving. Existing suicide prevention interventions have not focused on building positive affect. In this R34 treatment development grant we seek to develop a novel, individual skills-based, positive affect intervention, delivered adjunctively to treatment as usual (TAU), targeting the highest risk adolescents - those hospitalized due to suicide risk. Adolescents, regardless of diagnoses, with a recent suicide event will be recruited from an inpatient psychiatric unit. We focus on three strategies that have been demonstrated to increase sustainable (vs. transient) positive affect in community and depressed adults: meditation, gratitude, and savoring. There are multiple ways to learn and practice each strategy; thus we take into account patient preferences in a personalized approach in which patients select the practice(s) that fits best with their needs and circumstances. We propose using multiple means of intervention delivery that includes a new technology medium of their choosing, to reinforce in-vivo practice. The primary goal of this intervention is for patients to increase positive affect by incorporating skills and practices into their normal home-based routines, which we believe will lead to increases in problem-solving and social support and decreases in suicidal ideation. We propose the following: Development Stage 1. Develop the content of a Skills To Enhance Positivity Program (STEPP). STEPP includes two phases: a) in- person phase consisting of 3 individual in-person sessions and 1 joint parent session during the inpatient hospital stay to teach positive affect skills and develop a personalized intervention; b) remote delivery phase which consists of weekly telephone booster calls and daily text or email messages over 4 weeks post- discharge. The phone calls will be used to review or adjust personalized intervention components and reinforce use of skills. The text/email messages will include self-scripted reminders to practice skills and links to online resources. Text vs. email delivery will be based on accessibility and preference. 2. Administer STEPP in an open trial, using an iterative process, to 20 suicidal adolescents. Information from this trial will be used to improve the clarity, structure, content, acceptability, and feasibility of the intervention, in preparation for the pilot stage. Pilot Stage 1. Conduct a randomized controlled pilot study of STEPP vs. enhanced TAU (ETAU) in a sample of adolescent inpatients (n=50), ages 12-18 at risk for suicidal behaviors to assess the feasibility and acceptability of the proposed intervention and the randomization process. 2. Examine in an exploratory manner whether adolescents who received STEPP report a significant increase in positive affect compared to those receiving ETAU, at the end of each intervention phase and at 3- and 6- month follow-up intervals. 3. Examine in an exploratory manner whether an increase in positive affect, regardless of condition, is a potential mechanism of change for: a) reductions in suicidal ideation; b) improvement in perceived problem-solving; and c) improvement in perceived social support. Our treatment development objectives meet NIMH Strategic Objective #3, outlined in the report "From Discovery to Cure". This is a novel intervention for a high-risk acute population via a different mechanism (i.e. increasing positive affect), and conceptually distinct from other empirically examined theoretical approaches such as cognitive-behavioral therapy. We take into account the diverse needs of suicidal adolescents by 1) incorporating patient preferences in a personalized approach, 2) using multiple modalities of outreach, and 3) teaching home-based skills designed to be used independently to maximize broad access. Pilot stage data will be used to support the basis for a future, larger scale study, adequately powered to examine this intervention's efficacy in reducing suicidal behaviors in adolescents and to examine potential mechanisms of change.